GH12-008, NIGERIA, RESEARCH: HIV Drug Resistance: Implications for Optimizing Antiretroviral Therapy

ABSTRACT The worldwide scale-up of antiretroviral therapy (ART) has decreased HIV mortality and improved clinical outcomes in resource-limited settings (RLS), however, 20-30% of patients on ART typically experience detectable viremia after 12 months [1, 2]. As incomplete suppression is known to be a risk factor for developing drug resistance mutations (DRMs) [3], the development of resistance may erode global gains in the provision of ART [4-7]. In most RLS, a public health approach to choosing first-line (1L) and second-line (2L) ART is utilized [8]. For patients who fail a 1L regimen containing a specific NRTI backbone, the 2L NRTI backbone is expected to have preserved activity. However, in settings where detection of failure is delayed, the accumulation of DRMs may result in compromise of the 2L NRTI backbone. In addition to the concerns regarding NRTI susceptibility for 2L regimens, questions remain regarding the optimal time to switch a patient from 1L to 2L ART; for patients who are failing 1L, but have suboptimal adherence, it has been shown that with additional adherence interventions, patients re-suppress and actually had few or no resistance mutations [14]. There is a need to better understand the threshold and consequences of DRMs resulting from different patterns of non-adherence. Finally, little is known about the impact of accumulated DRMs on subsequent 2L outcomes. For this study, we propose to evaluate the DRMs among patients failing 1L ART, examine the patterns of adherence associated with the development of DRMs, and assess the association between DRMs and subsequent response to 2L ART. Through the analysis of DRM we hope to gain insight that can inform 1L regimen recommendations and increase our understanding of the risks associated with sub-optimal adherence on subsequent 2L outcomes. The proposed study will utilize data and samples from patients that have received ART at the Nigerian Institute of Medical Research (NIMR), Jos University Teaching Hospital (JUTH), and University College Hospital in Ibadan (UCH) in Nigeria. Through PEPFAR funding, all 3 treatment centers have been providing comprehensive HIV care and treatment services for over 8 years 21,138 patients currently on ART. Harvard has established the capacity for DRM genotyping at all three of these centers and will provide technical assistance and support.

Public health relevance
PROJECT NARRATIVE While the global scale-up of antiretroviral therapy (ART) has dramatically improved clinical outcomes in many resource-limited settings, nearly one-third of patients have a detectable viral load after 12 months and are at increased risk for developing drug resistance mutations (DRMs). For the subset of patients who fail, the choice of first-line ART as well as duration of failure may impact the efficacy of subsequent second-line ART. For this study, we will examine DRMs among patients failing first-line ART, with a focus on the nucleoside/nucleotide backbone, examine the patterns of adherence associated with the development of DRMs, and assess the association between DRMs and subsequent response to second-line ART with the goal of determining the optimal ordering of antiretroviral drugs to potentially impact future treatment recommendations. __SpecificAimsTextDelimiter__ SPECIFIC AIMS As a designated Federal Government of Nigeria ART Center, the Nigerian Institute of Medical Research (NIMR) has provided ART for over 11,000 patients. NIMR proposes to study the patterns of drug resistance after first-line (1L) failure, characterize adherence patterns associated with resistance development, and assess the impact of 1L drug resistance mutations on subsequent second-line (2L) ART outcomes. Such information may have important implications for the modification of treatment guidelines to improve overall treatment effectiveness and control drug resistance. This project will utilize data and samples from patients that have received ART at 3 large tertiary treatment hospitals: NIMR, Jos University Teaching Hospital (JUTH), and University College Hospital in Ibadan (UCH). Harvard will support these activities by providing technical assistance for the laboratory and biostatistical analyses. Aim 1: Determine the patterns of drug resistance among patients failing first-line regimens. NIMR will work with JUTH and UCH data staff to retrospectively identify patient samples for drug resistance mutation (DRM) analysis from a cohort of adult patients receiving ART at the 3 respective hospitals. It is hypothesized that the number of DRM will increase with duration on ART. It is also hypothesized that patients who receive tenofovir (TDF)-containing 1L ART will be more likely to retain activity to at least one nucleos(t)ide reverse transcriptase inhibitor (NRTI) after failure compared with patients who receive zidovudine (AZT) in the 1L regimen; our findings may have important implications for 1L ART recommendations, specifically the order in which NRTI drugs are used in 1L and 2L regimens. Aim 2: Examine the impact of ART adherence patterns on development of HIVDR. The research team will characterize the adherence patterns using both 3-day patient recall and average percent adherence (based on electronic pharmacy refill) for the total, 6- and 3-month periods preceding virologic failure. The team will examine the association between adherence and DRM development. In addition, median pill gap length, numbers of gaps, as well as overall gap days according to time on ART will be analyzed as predictors of mutation development. We hypothesize that patients with low adherence (<25%) will be more likely to harbor wild-type HIV as compared to patients with moderate to high level adherence (50-100%). We also hypothesize that the pattern of non-adherence will have an impact on the development of resistance and propose to identify the drug regimen-specific adherence threshold and dynamic relationship over ranges of adherence. Aim 3: Evaluate if there is an association between the presence or pattern of HIVDR and the response to WHO-recommended second-line ART regimens in patients failing first-line therapy. We will evaluate virologic outcomes at months 6 and 12 post-switch for patients switched to 2L ART and for whom genotype resistance testing was performed in Aim 1. We hypothesize that certain DRM patterns will be associated with lower rates of 2L success and/or durability over time. We expect that patients with e3 TAMS at the time of 2L switch will have lower rates of durable suppression than those patients with <3 TAMS over time.